Effects of on-demand and early neuromodulation interventions on bladder function after spinal cord injury

PROJECT SUMMARY
The prevalence of spinal cord injury (SCI) in the United States exceeds 350,000 individuals, with approximately
18,000 new injuries each year. Nearly everyone with SCI loses voluntary control of their bladder, and improving
bladder care is emphasized by people living with SCI as a critically important need. This is in large part because
current clinical management techniques, including catheterization and medications, fall short in addressing the
complexities of bladder dysfunction after SCI. Epidural spinal cord stimulation (SCS) over the sacral spinal cord
is a promising new approach and may be able to activate spinal reflexes and restore lower urinary tract control.
While surgical access to relevant lower urinary tract nerves in humans is difficult, SCS offers a clinically
established approach to activating these nerves on the surface of the spinal cord. Our preliminary findings
suggest that SCS can evoke both micturition and continence reflexes in anesthetized cats with intact spinal cords
and also after acute spinal transection. The challenge now is to evaluate whether it is possible to elicit functional
changes in the lower urinary tract after chronic SCI where permanent maladaptive changes occur in the neural
control of the bladder. We propose to use SCS in two innovative ways to regain bladder function following SCI.
In Aim 1 we will evaluate if both micturition and continence can be evoked in cats with chronic SCI by using
multiple stimulation frequencies. A closed-loop control system will use continuous bladder pressure
measurements acquired through an implanted telemetry system to control continence and micturition on
demand. In Aim 2, we will investigate an early intervention strategy to prevent maladaptive changes in the neural
control of the bladder that are the primary drivers of bladder overactivity. We will deliver long duration (~23
hours/day) SCS that begins immediately after SCI for up to 4 weeks, and measure the effects on reflexive bladder
contractions. This approach could slow or prevent bladder overactivity from occurring. The data generated from
this proposal will de-risk the future studies that will be aimed towards more comprehensively evaluating optimal
stimulation parameters in animal studies, but will also provide evidence to rapidly evaluate sacral SCS in people
with SCI.

Public health relevance
PROJECT NARRATIVE This exploratory study addresses a critical health concern for people living with spinal cord injury by asking whether spinal cord stimulation – a clinically available neuromodulation approach – can improve bladder function. We will first ask whether spinal cord stimulation over the sacral spinal cord can control both urine storage and emptying in awake animals with chronic spinal cord injury and will also ask whether a novel early intervention strategy could slow or halt the deterioration of bladder function that occurs after spinal cord injury. The results of this study will motivate parallel animal and human studies to improve the quality of life for people living with spinal cord injury.